Inflammatory Stress Promotes Clonal Expansion of DNMT3A-mutant HSCs

ABSTRACT
Blood diseases such as myelodysplastic syndromes (MDS) arise from hematopoietic stem cells (HSCs)
that acquire genetic mutations which corrupt critical HSC functions. One of the most recurrently mutated
genes in these neoplasms is the de novo DNA methyltransferase enzyme DNMT3A. However, DNMT3A
mutations can occur in HSCs long before clinical presentation. Recent studies have shown that the HSC
clones that predominate with age often contain mutations that are characteristic of myeloid neoplasms. This
phenomenon is known as clonal hematopoiesis (CH), but only a small fraction of individuals with CH go on to
develop a blood disease. This suggests that in addition to genetics, there must be other factors which act
differently between individuals that select for propagation of HSCs with these mutations. Our lab is interested
in identifying factors that change with age which may provide selective pressures for these mutant clones,
focusing on inflammation. The prior funding period identified interferon gamma (IFNg) as an environmental
stressor that selects for the outgrowth of Dnmt3a-mutant HSCs. While chronic IFNg signaling is detrimental to
normal HSCs, functionality of Dnmt3a-mutant HSCs is preserved in this setting, presenting a mechanism
whereby HSCs with these mutations gain clonal dominance in settings of inflammation. New data generated in
our lab show that Dnmt3a-mutant HSCs are not only resistant to the detrimental effects of IFNg in vivo, but
also the mutant clones produce more IFNg themselves in response to inflammation. This is associated with
increased Cxcl9 expression from the mutant clones and T-cell infiltration into the BM. These observations form
the scientific premise for this renewal application. We hypothesize that IFNg production by Dnmt3a-mutant
clones suppresses other HSC genotypes and remodels the niche through T-cell infiltration to further reinforce
their competitive advantage. We propose the following Specific Aims to investigate these questions;
 Determine if IFNg production from Dnmt3a-mutant clones exacerbates their competitive
advantage.
 Determine if Dnmt3a-mutant clones remodel the BM niche.
 Examine the cellular and molecular mechanisms by which Dnmt3a-mutant cells are
hypersensitive to IFNg.
The overall goal of this work is to determine the mechanisms by which inflammatory signals promote clonal
expansion of Dnmt3a-mutant HSCs in the bone marrow. Approaches to eliminate or selectively inhibit
emerging DNMT3A-mutant HSC clones from high-risk CH+ individuals may provide a window for intervention
before the mutant cells are able to establish clonal dominance and evolve to fulminant disease.

Public health relevance
PROJECT NARRATIVE Genetic mutations characteristic of myeloid neoplasms can be detected in the blood of up to 80% of healthy individuals over age 50 using sensitive genomic sequencing, a phenomenon termed clonal hematopoiesis (CH). While CH does increase the risk of blood cancer development, it does not predestine an individual for future disease progression, and as such, major unresolved questions are what factors promote expansion of these mutant clones in certain people and can these mechanisms be exploited to prevent disease progression in “at-risk” individuals? Here, we will investigate the role of inflammatory signals in providing a selection pressure for preferential growth of clones with DNMT3A mutations and identify novel points for potential disease interception.